Boosting NAD to Combat Heart Failure Sterile Inflammation

Heart Failure (HF) affects more than 6 million Americans with annual direct medical
expenditures exceeding $30 billion. Within the VA system, HF is prevalent among 5% of US
veterans with a disproportional annual mortality rate of 14.5%. A chronic sterile inflammatory state,
marked by sustained mild elevations of circulating proinflammatory cytokines, is associated with
poor clinical outcomes in HF. Large randomized trials that target specific cytokines, such as TNFα
and IL-1β, yielded variable results, indicating a knowledge gap in the mechanism linking
inflammation and HF. Specifically, it remains unclear what the inflammatory signals are and how
the peripheral immune cells—the primary effectors of inflammation—respond to and propagate
those inflammatory signals in HF. These gaps have halted the development of effective therapies.
Here, we postulate a novel model to mechanistically link inflammation to HF progression, such
that plasma extracellular vesicles (EV) encapsulating mitochondrial damage-associated
molecular patterns (MitoDAMP) serves as mediators to propagate the proinflammatory signal. On
the other hand, in pre-clinical and small clinical studies, boosting NAD+ has been shown to be
anti-inflammatory. Further, NAD+ deficiency is reported in pathologic states associated with
elevated inflammation, such as aging and HF. Our central hypothesis is that circulating immune
cells amplifies the MitoDAMP mediated inflammatory signal, and boosting NAD+ may be inhibitory
to this process. First, we plan to test hypothesis that the immunogenic factors in HF plasma are
the MitoDAMPs encapsulated in EVs. Second, given our preliminary data implicating monocytes
as a potential source of EV in HF plasma, we will study the cellular mechanism of EV release in
monocytes. Lastly, we will study how boosting cellular NAD+ by a metabolic precursor,
nicotinamide riboside (NR), may inhibit the monocytes from releasing EVs in vivo and in vitro. The
proposed study aims to define a novel HF disease mechanism that may ultimately lead to the
identification of new therapeutic targets. Completion of the proposed project will further my career
by positioning me in a scientific niche that intersects clinical HF and immunometabolism, providing
me with new research skills, and laying a strong foundation for my independent research program.

Public health relevance
Worldwide, heart failure (HF) is among the top causes of morbidity and mortality. In the United States alone, HF affects more than 6 million people with annual direct medical expenditures exceeding $30 billion. Within the VA system, HF is prevalent among 5% of US veterans with an annual mortality rate of 14.5%. Recent studies suggest chronic sterile inflammation contributes to HF progression; however, a failure to establish a causal relationship between systemic inflammation and HF outcomes has essentially halted progress in this field. Here, we propose to study how monocytes, a key player in HF inflammation, amplifies the MitoDAMP mediated inflammatory signal, and how boosting cellular NAD+ may be inhibitory to this process. In doing so, we aim to identify potential therapeutic targets for HF inflammation with the goal to improve the outcomes of Veterans who suffer from HF.